Core C: Product Analysis Core

SUMMARY: The WNY Center for Research on Flavored Tobacco Products (CRoFT) is focused on the
toxicity of flavorings used in tobacco products, with a particular focus on electronic nicotine delivery systems
(ENDS). Flavoring chemicals are an essential part of refill solutions used in ENDS products, waterpipe tobacco
and flavored cigars. To this end, most projects within CRoFT require data on the contents and/or emissions of
flavorings in products. The Product Analysis Core (PAC) will provide timely data on the chemical constituents
of products to be tested within the CRoFT and will inform projects about the relative popularity and product
variation of particular products and flavors. The underlying goal of the PAC core is to centralize the production
of data related to product features that can then feed the CRoFT projects, helping to improve research
efficiency. We plan the following three highly integrated Specific Aims:
AIM 1: Determine flavorings used and their concentrations in ENDS refill solutions, waterpipe tobacco products
and flavored cigars. We propose an approach to the identification and quantitation of flavoring chemicals in
tobacco products using GC-MS and GC-Q-TOF-MS methods. The testing of tobacco product will also involve
identifying flavoring ingredients that are carcinogenic, mutagenic, respiratory allergens, sensitizers and
irritants. We also will determine inter-product and intra-product variability in flavorings and determine intra- and
inter-brand variability in flavorings.
AIM 2: Determine flavoring yields and inhaled doses from ENDS aerosol and smoke generated from waterpipe
tobacco products and flavored cigars. After identification of flavorings in tobacco products in Aim 1, we will
measure flavoring yields in aerosol, smoke or vapor generated in laboratory settings using smoking machines.
We will also test generated aerosols for potential reaction and thermal breakdown products of flavorings. In
order to ensure compliance to the GLP standards, all tests will be done in a fully compliant quality system.
AIM 3: Monitoring trends in flavored tobacco product market share using secondary data analysis. In addition
to monitoring characteristics of products themselves, we will utilize market scanner data and PATH database
to identify the most common flavors in ENDS and other tobacco products and top-selling flavored ENDS
brands. Outcomes for Regulatory Science: In addition to providing relevant data for Projects 1-4, we will
develop an approach for toxicological risk assessment of flavors that takes into account the type and
concentration of flavoring chemicals in the tobacco products and aerosol/smoke/vapor, identification of any
potential thermal breakdown and reaction products, and respiratory risk assessment. This approach will
contribute to identifying any evidence of inhalation-specific issues that might make a compound unsuitable for
use in tobacco products. Results generated by the PAC can help to develop appropriate product standards
and implement robust quality management systems for flavorings in tobacco products.